Metabolic Reprogramming of the Alveolar Stem Cell Niche in Pulmonary Fibrosis

PROJECT SUMMARY
Cell metabolism regulates epigenetic reprograming to determine cellular identity and fate.
Intermediary metabolites serve as essential cofactors for epigenetic modifying enzymes. Epithelial-
mesenchymal crosstalk is critical for the maintenance of adult tissues/organs and in regenerative
responses to tissue injury. In the lung, alveolar maintenance and regeneration are orchestrated by the
interaction of alveolar type 2 (AT2) cells, a facultative stem/progenitor cell population, with the
adjacent mesenchyme that contributes to “niche” support of the regenerating epithelium. These
homeostatic type 2 niche-supporting stromal cells (T2NSCs) may transition to pathological
mesenchymal states/fates during lung injury-repair.
We have identified a metabolic enzyme, nicotinamide N-methyltransferase (NNMT), that regulates
the plasticity of tissue-resident fibroblasts (FBs) and the transition of lipofibroblasts (lipo-FBs) into
myofibroblasts (myo-FBs). NNMT catalyzes the N-methylation of nicotinamide and other pyridine
compounds; by utilizing the universal methyl donor, SAM in this reaction, NNMT functions as a
“methyl sink” in many tissues, while also depleting cellular NAD+ levels. Our data indicate that NNMT
is upregulated in lung mesenchymal cells of idiopathic pulmonary fibrosis (IPF), and is induced by the
pro-fibrotic cytokine, transforming growth factor-β1, in human lung fibroblasts. NNMT functions as a
critical switch from lipo-FB to myo-FB differentiation that acquire apoptosis resistance, thus impairing
fibrosis resolution.
In this project we will test the hypothesis that metabolic-epigenetic reprogramming of activated
stromal T2NSCs by targeting NNMT potentiates lung regenerative capacity and facilitates fibrosis
resolution by augmenting cellular levels of NAD+ and/or SAM. Our specific aims are to: (1) identify
T2NSCs subpopulations and characterize their regulation by NNMT; (2) determine mechanisms by
which NNMT regulates lipo-FB to myo-FB transition; and (3) determine whether targeting NNMT
accelerates fibrosis resolution in an animal model of lung injury-induced fibrosis. A combination of
bulk and single-cell RNA-seq, ATAC-seq, metabolomics, bioenergetics, and epigenetic profiling in 3D
alveolospheres, IPF lung FBs, and an in-vivo lung injury model will be employed. The studies
proposed in this grant application will advance the field by identifying a critical regulatory switch in
lipo-FB to myo-FB differentiation, linking metabolism to epigenetics by an enzyme that controls both
cellular bioenergetics and protein methylation, defining a therapeutic strategy that achieves fibrosis
resolution/reversal in established lung fibrosis, and elucidating a functional role of alveolar stem cell
niche-supporting fibroblasts in stem cell rejuvenation and tissue regeneration.

Public health relevance
PROJECT NARRATIVE Pulmonary fibrosis is linked to a failure of regeneration that involves epithelial-fibroblast interactions. This project will study the role of a metabolic enzyme, nicotinamide N-methyltransferase (NNMT), that reprograms cellular function and behavior of fibroblasts from a pro-regenerative to a pro-fibrotic phenotype.